Genomics and Cell Biology Core

PROJECT SUMMARY/ABSTRACT
The overall goal of the Genomics & Cell Biology Core will be to facilitate the application of cutting-edge
genomics, bioinformatics, cell biology, and immunology techniques to nutrition and metabolic research. This
will be accomplished by encouraging multi-disciplinary approaches and collaborations to study nutrition-related
topics, and by overcoming the barriers to using complex and expensive techniques by providing appropriate
consultation and training to NORCH Investigators. The guiding philosophy of the Genomics & Cell Biology
Core is that although many projects can be advanced by the use of sophisticated genomic and cell biology
techniques, their expense and difficulty of first use represent a significant barrier. The Core is specifically
designed to overcome this barrier by providing personalized consulting and training to NORC-H investigators
that is not typically available in most NGS, genomics, bioinformatics, cell biology, or immunology core facilities.
Following the retirement of Core Director Dr. Fred Ausubel (who has been the Director of Genomics Core since
the original inception of the Center grant since 1994), Dr. Alessio Fasano, a renowned Celiac disease
researcher and previously and Co-Core Director, has assumed the role of Director. The Co-Associate Director
(Bioinformatics and Next Generation Sequencing) Dr. Ruslan Sadreyev, and Co-Associate Director (Cell
Biology) Dr. Haining Shi will remain in charge of respective parts of the Core. There are 5 specific Aims of the
Core: 1) provide consultative services related to genomics, cell biology, and immunology research design; 2)
provide space, technical personnel, and specific training and supervision for utilizing specialized techniques
and equipment used in cell biology, immunology, and genomics research, including single-cell transcriptional
and epigenomic profiling, assistance in the development of high-content high-throughput assays using
automated microscopic imaging, fluorescent activated cell sorting, and development of animal models; 3)
provide a variety of genomics-related services related to next-generation sequencing; 4) provide bioinformatic
analysis of various types of high-throughput data, including bulk and single-cell RNA-Seq, ATAC-seq, ChIP-
Seq, CUT&RUN, Hi-C, metagenomics, proteomics, as well as computational analysis of molecular pathways,
networks and phenotypes; and 5) conduct enrichment tutorials and workshops in basic concepts in genomic,
bioinformatic, cell biology, and nutrition and GI immunology-related techniques, and coordinate summer
internships for undergraduates and medical students. This will be accomplished through the significant
expertise of the Core Directors and staff, with the help of advanced instrumentation for bioinformatics analysis,
most up-to-date next generation sequencing instruments, automated microscopy and imaging based high
content screening assays, a variety of equipment for carrying out immunological, cell biology, and morphology-
related assays.